Developing near-infrared responsive liquid crystal elastomers for an adjustable pulmonary artery band

Project Summary
Approximately 1 in 100 children born in the United State have a congenital heart defect (CHD). Nearly a
quarter of these children present with “critical” CHDs, requiring surgical intervention within the first year of life.
For patients in which a CHD is the source of pulmonary hypertension (e.g., the unrestricted flow of blood to the
lungs), a palliative pulmonary artery band (PAB) can be applied to regulate blood flow. Conventional PABs are
fixed and thus commit children to repeated surgeries if adjustments are needed due to altered hemodynamics
and/or to accommodate growth. As a result, the affected children suffer from high morbidity and mortality. This
proposal addresses this clinical need by developing and optimizing novel stimuli-responsive materials for
integration with PABs to permit adjustability.
Light is an ideal stimulus to introduce minimally invasive reconfigurability to the PAB. The objective of
this research activity is to integrate photoresponsive materials with PABs to enable the diameter of the PAB to
be reconfigured via light delivered by an endovascular fiber-optic catheter through the artery wall. Aim 1 is
focused on material development and integration into novel PAB designs that leverage the stimuli-responsive
material. Aim 2 will assess the cellular and host responses to the stimuli-responsive material and develop
strategies to engineer these responses if necessary. Long-term, the evolution of stimuli-responsive materials will
lead to a wide variety of growth-accommodating and shape-changing medical devices that will improve patient
outcomes and quality of life.
This collaborative research project will be undertaken at the University of Colorado Boulder with
mentorship and support from Dr. Timothy White and Dr. Kristi Anseth. The training plan includes development
of technical skills (e.g. polymer chemistry, medical device design, and biological testing of biomaterials) and
professional skills (e.g. communication skills, career development, and scientific outreach). In sum, this
application will provide the applicant with invaluable training for his future career as a surgeon-scientist focused
on translating novel biomaterials into impactful medical devices and technologies.

Public health relevance
Project Narrative Congenital heart defects (CHDs) are a major global health burden, responsible for over 250,000 deaths annually and lasting complications for the estimated 12 million people living with CHDs. Without the ability to substantially alter the prevalence of CHDs, new medical technologies are needed to improve survival and quality of life. The goal of this proposal is to develop a stimuli-responsive material that can be integrated with existing medical devices, such as pulmonary artery bands, to permit adjustability acutely (e.g. due to physiological changes) and chronically (e.g. to accommodate growth) thereby improving patient outcomes and reducing costs.